BedsideNotes: Engaging families to improve pediatric safety

PROJECT SUMMARY/ABSTRACT
This career development proposal will provide Dr. Michelle Kelly, a Pediatric Hospitalist Physician at the
University of Wisconsin School of Medicine and Public Health, with the training and mentorship required for
success as an independent, physician-scientist leveraging tools and technologies supporting family
engagement to improve the quality and safety of care of hospitalized children. Dr. Kelly has championed efforts
to promote family engagement, including redesigning hospital rounds to include families and implementing a
bedside portal – an online application giving families’ access to parts of their child’s inpatient medical record.
She has attained an MS in Clinical Investigation to develop skills in conducting literature reviews, analyzing
quantitative data, and designing clinical and translational studies. Building on this foundation, her proposed
K08 career development plan focuses on three knowledge gaps: qualitative methods, human-centered design
of interventions to support health communication and literacy, and systematic intervention implementation and
evaluation. With the protected time afforded by this award for coursework, participation in national meetings
and mentored research, Dr. Kelly will attain the critical skills necessary to develop and disseminate healthcare
interventions. In her proposed research plan, she will develop BedsideNotes as a model intervention and
implementation bundle. This bundle will consist of expanding the bedside portal to share inpatient doctors’
admission and progress notes with families and complementary implementation strategies to optimally support
family engagement while mitigating unintended negative consequences. She will develop this bundle using
these aims: 1) identify family and clinician perspectives of barriers, facilitators and strategies to share inpatient
doctors’ notes; 2) develop BedsideNotes design requirements; and 3) implement and evaluate the feasibility
and preliminary efficacy of BedsideNotes in a pilot study with families of hospitalized children. This proposed
study responds directly to NOT-HS-13-011 and addresses multiple research areas, including health IT design
and implementation, and will provide preliminary data describing the use and impact of health IT on family
engagement and patient safety outcomes. As faculty at an institution with extensive research infrastructure, Dr.
Kelly is in an ideal environment to complete this proposed research and pursue advanced training. Her career
development plan includes protected time for coursework and mentorship from a committed team of experts in
human factors and systems engineering, patient safety, qualitative methods, health communication/literacy,
pediatric ethics, and health IT intervention design, implementation, evaluation and dissemination. At the end of
this project, Dr. Kelly will have the preliminary data necessary to support a competitive R01 proposal in which
she will test whether this intervention improves family engagement and safety concern reporting. This K08
award will also allow her to achieve her goal of independently leading a program leveraging tools and
technologies to improve the safety of care of hospitalized children, an AHRQ priority population.

Public health relevance
PROJECT NARRATIVE Hospitalized children suffer harm from medical errors at a rate three times that of adults and depend on clinicians to partner with their families to improve patient safety. Sharing doctors’ notes, which detail their diagnoses, treatment and contingency plans, has prompted adult outpatients to identify safety concerns, over half of which resulted in changes of care. Extending this work to hospitals, the objective of this proposed research is to design an intervention, BedsideNotes, to share doctors’ inpatient notes with families at the bedside to engage them in the care of their hospitalized child and partner with them to prevent harm.